To decode and to modulate the emotional aspect of pain

To decode and to modulate the emotional aspect of pain
Abstract
It is well known that pain contains both a sensory-discriminative and an emotional component. While the
sensory-discriminative aspects of pain are easily quantifiable, quantitative measures of “emotions” are
generally lacking, particularly in preclinical animal models where subjects cannot verbally relay their
emotional state. Notably, emotions are all intimately associated with bodily autonomic responses. In
preliminary studies in mice, we have measured heart rate responses in acute pain models and discovered
that formalin pain dramatically reduces heart rate variability (HRV) while moderately affects heart rate (HR).
In aim 1, we will systematically characterize several autonomic responses to identify key autonomic
signatures for different mouse pain models. Furthermore, we previously identified general anesthesia
activated central amygdala (CeA) neurons (CeAGA) as potent pain-suppressing neurons. Exciting
preliminary data revealed that activating CeAGA neurons reduced HR and significantly increased HRV,
suggesting that the pain-suppression effect of these neurons is in part due to reversing pain-elicited
autonomic responses. In aim 2, we will perform in vivo imaging and functional manipulations of two
populations of CeA neurons (CeAGA and CeASst) with concurrent measurements of autonomic responses
and behavior in acute and chronic pain models to determine how their activity is causally linked to different
patterns of autonomic and behavioral responses. Finally, it is known that past pain experience leads to
hypervigilant and anticipatory responses to similar sensory stimuli. Human studies suggest that receiving
information about upcoming pain can preemptively elicit autonomic responses. We have established a new
pain anticipation paradigm in mice where we can clearly observe the nocebo effect. We also identified pain
anticipatory neural signals in the midline thalamic nuclei (MT). In aim 3, we will dissect the role of specific
populations of MT neurons in driving anticipatory autonomic and behavioral responses when mice expect
upcoming pain and the consequent nocebo responses using in vivo imaging and functional manipulations.
We expect that the proposed research will break new ground in our understanding of the emotional aspects
of pain. Ultimately, this knowledge can be used to develop non-addictive, non-surgical chronic pain
treatments that remove the negative affective component of pain.

Public health relevance
Narrative We will systematically characterize autonomic response signatures of different pain models and delineate how key subcortical brain centers (central amygdala and midline thalamus) process the emotional aspect of pain by directly controlling these autonomic responses. The proposed research is expected to break new ground in our understanding of the emotional component of pain and provide much needed knowledge for developing future non-addictive, non-surgical treatments of chronic pain.